Center for Structural Biology of HIV RNA

Development Core
The objectives of the Development Core are to extend the impact of the Center’s activities to the next generation
of scientists by engaging early career scientists or investigators new to HIV in limited-duration funded
collaborations with Center investigators, to enrich the training environment within the Center for students,
postdoctoral fellows, and early career investigators by providing educational activities and mentoring, and to
broaden the Center’s outreach by welcoming undergraduate scholars from diverse backgrounds into CRNA
research groups to provide these learners with introductions to biomedical research. These objectives will be
achieved by (1) Establishing a vigorous collaborative development plan, through which scientists outside the
core CRNA membership can contribute to and benefit from the CRNA (2) Conducting Hands-on Workshops that
enable collaborations and promote the exchange of Center expertise by engaging trainees in in-depth
introductions to the use and collaborative capabilities of the Center’s advanced technologies (3) Providing
mentoring to trainees and facilitating their interdisciplinary research progress by providing Center trainees with
engaged feedback on their scientific presentations and with opportunities to engage in laboratory training
exchanges among research groups and (4) Helping foster the next generation of scientists by providing research
and educational experiences in CRNA labs for undergraduates from diverse backgrounds.